ANTI-TAG 72 MONOCLONAL ANTIBODY IN HORMONE RESISTANT PROSTATE CANCER

The purpose of this study is to examine the safety and efficacy of radioactive monoclonal antibody therapy when combined with external beam radiation as a treatment for hormone resistant prostate cancer.